A New Opportunity for Protecting Zebrafish Genetic Resources: Development of a Reproducible Repository System for Community-driven Cryopreservation

PROJECT SUMMARY/ABSTRACT:
Zebrafish (Danio rerio) is one of the most used animal models in biomedical research, and laboratories around
the world produce thousands of new genetic lines each year. Establishment of reproducible germplasm
repositories through sperm cryopreservation is critical for protection and sharing of valuable genetic resources
of aquatic organisms that are vital to advancing biomedical research. The Zebrafish International Resource
Center (ZIRC) was established to serve as a central repository for genetically modified research lines. In
collaboration with the Aquatic Germplasm and Genetic Resources Center (AGGRC) at Louisiana State
University Agricultural Center, ZIRC has transitioned successfully from live animal maintenance to high-
throughput repositories of cryopreserved sperm. Efficient management of zebrafish genetic lines is extremely
important for the research community that uses the zebrafish model to advance biomedical research. Despite
this past success, the accelerating number of new research lines is on a path to overwhelm the processing
capacity at ZIRC. The reasons for this crisis are rooted in the rapid advancement of genetic editing techniques,
and a lack of community-level capabilities to reproducibly cryopreserve sperm in individual laboratories. Less
than 1% of zebrafish research laboratories cryopreserve sperm or submit cryopreserved samples to ZIRC. As
such, the zebrafish research community has an urgent need for resources to transition from ZIRC-led sperm
cryopreservation to a community-driven cryopreservation approach. The goal of the proposed project is to
develop a new resource system to provide individual laboratories with decentralized capabilities of reproducible
sperm cryopreservation and quality management at the community level. These resources address specific
community needs for community-level standards integrated with open hardware to enable reproducible
capabilities and training platforms. In contrast to our previous center-focused R-24 projects, this proposed work
will employ a user-focused approach, with the principle that any resources developed should be directly
accessible, usable, and reproducible by a majority of members of the zebrafish research community.
Interdisciplinary innovations will be necessary, including development and integration of 3-D printable open
hardware, industrial process management approaches, comprehensive user-ready technology packages, user
experience (UX) design methods, and large-scale fabrication and manufacturing. The Specific Aims are to:
1) Establish community-level standards for sample processing and quality management; 2) Develop
comprehensive technology packages with open-source hardware to enable community access to decentralized
reproducible cryopreservation capabilities, and 3) Develop online resource platforms to engage the user
community. These advances will greatly assist ZIRC and the zebrafish community, and will extend beyond the
lifetime of the grant, providing a roadmap for germplasm repository development for other biomedical models.

Public health relevance
PROJECT NARRATIVE: The thousands of novel zebrafish (Danio rerio) genetic lines that are created and utilized by biomedical research each year raise a growing concern that even the expanded processing capability at the Zebrafish International Resource Center (ZIRC) will soon be overwhelmed, and thus there is an urgent need for the zebrafish community to transition from centralized, ZIRC-centered cryopreservation processing to a reproducible, community-driven strategy through systematic capability development. The most significant problems hindering this transition are the systemic lack of capability among 99% of the aquatic research community for reproducible cryopreservation, as well as a lack of means for quality management and reproducibility which prevent coordination among laboratories and stock centers, jeopardize maintenance of valuable lines, and produce costly inefficiency that slows research progress. To address these problems, we will use innovative interdisciplinary research to develop a new resource preservation system to empower individual laboratories with decentralized capabilities for reproducible sperm cryopreservation and quality management that can operate at the community level.